Sedentary Behavior and Cardiovascular Health in Young Women

ABSTRACT
Women have more rapid cardiovascular disease (CVD) risk development compared to men during young
adulthood; yet, little research has studied factors that could curtail CVD risk development during this critical
period for young women. The Nulliparous Pregnancy Outcomes Study Monitoring Mothers-to-Be Heart Health
Study (nuMoM2b HHS) is a unique, multi-center, longitudinal cohort, originating during the first pregnancy, that
is now studying associations between adverse pregnancy outcomes (APO) and modifiable CVD risk in women.
This ancillary application to nuMoM2b HHS aims to test our hypotheses that sedentary behavior (SED) is a key,
modifiable risk factor for CVD risk development in young women, including those with APO.
SED is low-intensity behavior in a seated, reclining, or lying posture and has recently been identified as a CVD
risk factor that is distinct from insufficient moderate-to-vigorous intensity activity (MVPA). Acute prolonged sitting
results in marked, adverse responses such as increased blood pressure (BP), glucose, and lipids. Yet, major
research gaps preclude the development and testing of specific SED-reduction interventions, especially for
young women. Most studies measure SED poorly (e.g., by self-report) and do not statistically consider that SED
is part of an all-day activity pattern (or composition). Further, mechanisms of how SED leads to CVD are unclear,
further limiting intervention development. Last, almost no studies focus on young women. Our preliminary data
suggest that SED is strongly associated with APOs and reduced cardiovascular health (e.g., BP) in young women
post-pregnancy. Further, our laboratory has recently demonstrated novel associations between SED and
mechanistic CVD measures, including greater arterial stiffness (higher pulse wave velocity [PWV]) and worse
autonomic function (lower heart rate variability [HRV]). Collectively, SED is a novel, understudied risk factor for
reduced cardiovascular health that our data suggest is highly relevant for young women.
We have a unique, efficient, and time-sensitive opportunity to address these gaps by adding gold standard
SED assessment via activPAL thigh-mounted accelerometer to the upcoming HHS2 exam. In this contemporary
and diverse female cohort (n=4,050, age=36±6 years), we aim to quantify cross-sectional and longitudinal
associations of SED with the clinical components of idea cardiovascular health (BP, BMI, total cholesterol, fasting
glucose) by using state-of-the-art statistical methods that consider the compositional nature of SED and 24-hr
activity and can correct existing, longitudinal self-reported SED via regression calibration. Also, we add HRV and
PWV in Pittsburgh and Indiana (n=950) to efficiently study associations between SED and subclinical,
mechanistic CVD outcomes in young women. Aim 3 will study interrelationships of SED, APO history, and ideal
cardiovascular health to identify novel risk reductions strategies in this high-risk group with limited treatment
options. This research will provide critical data to rigorously link SED, CVD risk, and contributing mechanisms
and will inform age- and sex-specific SED interventions to test in young women, including those with APO.

Public health relevance
PROJECT NARRATIVE Reducing sedentary behavior is a new strategy that may improve cardiovascular health among young women, a group recently identify as having accelerated, sex-specific cardiovascular risk development that is even higher when the woman has experienced an adverse pregnancy outcome. This project seeks to thoroughly and efficiently investigate relationships between sedentary behavior and all-day activity patterns with ideal cardiovascular health components (blood pressure, body mass index, cholesterol, and glucose) by conducting an ancillary study set within an existing longitudinal cohort of more than 4,000 young women (i.e., Nulliparous Pregnancy Outcomes Study Monitoring Mothers-to-Be Heart Health Study [nuMoM2b HHS]). By adding gold standard sedentary behavior measurement, using emerging statistical methods in physical activity epidemiology, and adding measurement of subclinical cardiovascular mechanisms that could link sedentary behavior to cardiovascular disease outcomes, this study has high potential impact to inform novel behavioral interventions that may reduce cardiovascular risk development among young women.